Augmenting the Quality and Duration of the Immune Response with a Novel TLR2 Agonist-Aluminum Combination Adjuvant

The goal of this project is to optimize a novel adjuvant formulation composed of alum and a TLR2 agonist to improve performance of a DTaP subunit vaccine.